2024 Bioanalytical Sensors Gordon Research Conference and Gordon Research Seminar

PROJECT SUMMARY
Sensors designed both for analytical performance and usability have the potential to turn the tide of pandemics,
bridge gaps in healthcare disparities, and provide insight into biological processes. Because of the prominent
roles sensors and diagnostics play in our current lives and their potential for massive future growth, establishing
a diverse and global community of experts to discuss outstanding challenges and the possible approaches for
solving them is a key need with

Public health relevance
PROJECT NARRATIVE The Gordon Research Conference on Bioanalytical Sensors (GRC-BAS) aims to promote the dissemination, discussion, and implementation of cutting-edge biological, biomedical, and biomolecular technologies that can The will highlight topics that include the development and real-world validation of point-of-care diagnostics, patient-centric solutions, and wearable sensors, while highlighting the innovations required to enable this impact. improve health around the globe. 2024 GRC-BAS Funding the GRC-BAS will support collaboration between life scientists, physical scientists, engineers, and medical professionals to propel basic and applied research directions, advance medical technologies, and ultimately improve patient care.